Cognitive and reward signals for choices under ambiguity

Abstract
Poor decisions can have severe consequences, and impaired decision-making behavior is a symptom of many
neurological and psychiatric disorders. Decision theory recognizes two forms of uncertainty: risk – in which the
underlying probability distributions are known, and ambiguity – in which the underlying probability distributions
are not known. Risk is the conceptual foundation for the Expected Utility theory. Despite its enduring influence
in economics, this theory fails to adequately describe real-world choice behavior. One reason is that pure risk is
rare: it is only encountered in casinos, coin-flips, and decision-making experiments. In the real world, incomplete
information, sparse data, and cognitive limitations create states of uncertainty that exist on a spectrum between
pure risk and blind ignorance. Therefore, ambiguity, rather than risk, describes the conditions under which most
decision-making occurs. In ambiguous circumstances, it is impossible to calculate expected utilities. Instead,
decision makers (consciously or subconsciously) substitute beliefs for expected utility estimations, and this has
consequences for healthy individuals and those with neurological and psychiatric disorders. Healthy decision
makers exhibit ambiguity aversion: they avoid ambiguous prospects, even when doing so is costly. Individuals
with prefrontal dysfunctions perform poorly during choices under ambiguity, even when choices under risk remain
relatively intact. Despite the prevalence of ambiguity and its consequences, it is not known how neurons code
for the uncertainty associated with ambiguity, or how these neural estimates are used for decision making. To
understand how neural circuits implement economic choices and how this implementation may be altered with
prefrontal dysfunction, we will use a non-human primate model to characterize the contributions of cognitive and
reward systems to decisions under ambiguity, and to provide a mechanistic understanding of ambiguity aversion.
The central hypothesis of this project is that ambiguity aversion results from the metacognitive appraisal of
probability judgements. In other words, it is not beliefs, but rather decision makers’ confidence in those beliefs,
that causes ambiguity aversion. We will use behavioral analysis, neurophysiology, and genetically coded
silencers to probe the functions of dorsolateral prefrontal cortex and dopamine neurons and answer three
fundamental questions. (1) How is ambiguity coded and transformed into beliefs? (2) What are the roles of
cognitive systems in estimating ambiguity and making good choices? (3) How does confidence in probability
judgements affect decisions? We predict that uncertainty coding in dorsolateral prefrontal cortex will be less
reliable in ambiguous, when compared to risky, conditions and lead to lower certainty, lower confidence, and,
ultimately, ambiguity aversion. Our results will increase understanding of the neural basis of decision-making
under ambiguity and provide insights into diagnosis and treatment options for an array of human disease states.

Public health relevance
Project Narrative In most real-world conditions, decision makers do not know the probabilities associated with potential outcomes – a state of uncertainty that is defined as ambiguity. Decision makers exhibit ambiguity aversion, preferring to avoid ambiguity even at a cost to themselves, and patients with prefrontal dysfunctions perform especially poorly during choices under ambiguity. This research project seeks to understand the neurophysiological basis for choices under ambiguity; these results will shed light on neural mechanisms for real-world economic choices and provide mechanistic insights into the severe decision-making deficits associated with mental health disorders.